The Role of Developmental Dysanapsis in Lung Development Throughout the Lifespan in Experimental Bronchopulmonary Dysplasia

Bronchopulmonary dysplasia (BPD), the chronic lung disease following preterm birth, is the most
frequent complication of prematurity. Infants who develop BPD are at high risk for death and have
substantial life-long morbidity. Despite decades of research, the biomechanical mechanisms that
cause sustained lung development abnormalities after preterm birth and optimal strategies for the
prevention and treatment of BPD remain poorly understood.
Recent evidence suggests that the chronic respiratory failure of BPD may be due to
disproportionate growth of lung compartments. Dysanapsis is the concept of disproportionate
airway and distal lung growth. Prior work in experimental BPD has shown that intra-amniotic
endotoxin causes dysanaptic growth of the airways and parenchyma in infant rats. It is unknown
whether dysanaptic growth affects the trajectory of lung function over a lifetime. Given that
vascular growth occurs in parallel with alveolarization during lung development, disruption of
airway-airspace growth likely implies disrupted growth of the vasculature.
This proposal will test whether there is persistent dysanaptic growth of airways, distal
parenchyma, and vasculature in experimental BPD, and whether these structural changes
contribute to persistent impaired biomechanics, pulmonary hypertension, and increased
susceptibility to postnatal insults. First, we will determine whether intra-amniotic endotoxin causes
dysanaptic lung growth that persists throughout postnatal lung development (Aim 1). Then, we
will investigate whether impaired vascularization occurs in parallel with dysanaptic growth of the
airways and parenchyma (Aim 2). Finally, we will test whether dysanaptic growth after intra-
amniotic endotoxin increases the risk for worsened lung function trajectory after acute postnatal
inflammation (Aim 3).
In addition to expanding the understanding of interactions between airways, alveolar, and
vascular growth and the long-term functional implications of dysanaptic growth, this K38 proposal
would allow me to build scientific expertise early in my career. The K38 StARRTS program would
provide the support and mentorship to transition from a resident physician in the R38 StARR
program to a strong candidate for a future K08. My career development plan includes time to 1)
advance my understanding and use of preclinical models to study lung structural development,
2) learn skills to design and perform experiments assessing vascular structure and development,
3) to perform robust and non-biased data analysis, and 4) develop strong written and oral
communication skills.

Public health relevance
Project Narrative: Bronchopulmonary dysplasia (BPD), the chronic lung disease following preterm birth and the most frequent complication of prematurity with persistent mortality and substantial life-long morbidity. Our lab has shown that there is a disproportionate, dysanaptic growth pattern in airways and airspace in experimental BPD. This proposal will utilize a rodent model of chorioamnionitis- induced BPD to study interactions between airway, parenchyma, and vascular growth over the lifespan, and how antenatal stress contributes to long-term growth and susceptibility to future insults which will lead to further understanding of the biomechanical mechanisms that cause sustained lung development abnormalities after preterm birth, as well as the perinatal origins of adult lung disease.